Nebraska Research Network in Functional Genomics

Integrated Imaging Core
Project Summary
Light microscopy, used on live and fixed cells as well as tissues, has become one of the most important techniques
for modern biomedical researchers. Moreover, the recent breakthroughs in super-resolution microscopy, that now
enable scientists to “surpass” the diffraction barrier and use light microscopy to resolve structures approaching
the nanometer levels, have further increased the importance of access to state-of-the-art advanced microscopy
equipment and the availability of application experts to train and/or guide users in acquisition and proper
interpretation of data. The goal of the NE-INBRE Imaging Core Facility is to make NE-INBRE investigators more
competitive for research funding by making available the very best possible confocal microscopy and advanced
imaging services. The NE-INBRE NIICF is an integrated core facility jointly comprised of the UNMC-Advanced
Microscopy Core Facility (UNMC-AMCF) and the CUMC-Integrated Biomedical Imaging Facility (IBIF). This newly
developed joint core is better aligned with the needs of the NE-INBRE network. The joint equipment and expertise
available at the NE-INBRE Imaging Core Facility has enhanced research at both medical schools, and across the
entire state of Nebraska by allowing access and providing support for users to incorporate light microscopy and
related technologies including multi-photon confocal microscopy, Super-resolution Structured Illumination
Microscopy (sr-SIM), and single molecule imaging by direct Stochastic Optical Reconstruction Microscopy and
PhotoActivatable Localization Microscopy. The NIICF will continue to provide users at UNMC and CUMC with
outstanding and advanced microscopy equipment. In addition, the NIICF will also continue to provide the services
of a PhD-level applications specialist who not only is qualified to acquire data, but can also help with experimental
design and quantification of data, as well as interpretations of experimentation. These services are available and
especially important for the PUIs.